Integration of biophysics and deep learning to understand species-specificity of fertilization and the rapid evolution of protein disorder

Project Summary
Proteins often fold into three-dimensional shapes and operate as cellular machines with well-defined
reaction mechanics – hence the common biochemical expression “structure is function.” However, this rule
only applies to the slowest evolving portions of the human genome. Proteins that evolve more rapidly are
typically less ordered, both enabling their accelerated evolution and expanding the biochemical landscape on
which natural selection may act. Currently there exist few tools and conceptual frameworks to understand the
sequence-function relationship of quickly evolving dynamical proteins. Across the tree of life, reproductive
proteins evolve at extraordinary rates – typically faster than immune genes – and the Wilburn lab studies the
biophysics and molecular evolution of species-specific fertilization in animals. The continuous coevolution of
interacting sperm and egg proteins has selected for biochemical properties such as intrinsic disorder, weak
binding affinities, etc. that complicate their study. High-field NMR spectroscopy is unique among structural
methods in its ability to study such heterogenous protein systems, and I have pioneered NMR studies of
fertilization proteins in a classic model of fertilization research (marine abalone). Over the next 5 years, we will
interrogate the sequence-to-function relationships of gamete recognition proteins important for species-specific
fertilization by pairing high throughput mutagenesis screens with targeted biophysical analyses to better
understand the complex interplay of molecular dynamics with protein evolvability and interaction kinetics. NMR
methods will be expanded to the study of mammalian fertilization proteins. To facilitate our own work and
empower other researchers, deep learning-based analytical tools in evolutionary genomics, mass spectrometry
proteomics, and NMR dynamics will be developed. The proposed research will provide an evolutionary
framework to better understand the breadth of protein biochemistry encoded by the human genome, and
includes diverse training opportunities for undergraduate, graduate students, and postdocs

Public health relevance
Project Narrative A paradigm of molecular evolution and biophysics is that proteins adopt regular three-dimensional shapes necessary for their cellular functions, yet recent studies of intrinsically disordered proteins support that protein dynamics contribute to both functional plasticity and evolvability over millions of years. The goals of this R35 MIRA are to integrate high throughput mutagenesis screens with biophysical assays and the development of new deep learning models to understand how rapid evolution shapes molecular dynamics and interfaces. These questions will be explored using species-specificity of fertilization as a model.